Endothelial-to-osteoblast transition in prostate cancer bone metastasis

Project Abstract/Summary
Bone metastases are the major contributing factors to prostate cancer (PCa) morbidity and mortality. PCa bone
metastases are uniquely osteoblastic and characterized by new bone formation, which promotes tumor growth in
bone. Thus, bi-directional interaction between the PCa cells and their mis-induced bone plays a critical role in PCa
progression in bone. It has been assumed that metastatic PCa induces new bone formation by stimulating the
proliferation of osteoblasts in the bone marrow. However, we recently demonstrated that tumor-associated
endothelial cells could give rise to osteoblasts through a little-appreciated process known as endothelial cell-to-
osteoblast (EC-to-OSB) conversion, generating in the process EC-OSB hybrid cells with unique properties. Our
studies showed that tumor-induced EC-to-OSB conversion is one mechanism that leads to osteoblastic
bone metastasis of PCa. This new insight into the surprising bone-forming role of EC-OSB hybrid cells in PCa
bone metastasis provides a novel rationale to target these cells in the tumor microenvironment.
We hypothesize that tumor-induced EC-to-OSB conversion generates EC-OSB hybrid cells, which provide
paracrine factors to support metastatic PCa growth in bone. Our objective is to target EC-OSB hybrid cells for
improving therapy for bone metastasis. We will: Aim 1. Determine the mechanisms underlying endothelial
cell-to-osteoblast (EC-to-OSB) transition. EC-to-OSB conversion requires both the inhibition of angiogenesis
and activation of osteoblastogenesis pathways in endothelial cells. Our preliminary results indicate that BMP4
activates the Notch-Hey1 pathway to inhibit angiogenesis and the p38MAPK-β-catenin-OSX pathway to stimulate
osteogenesis. We will examine how BMP4 integrates these two pathways to reprogram the endothelial cells. Aim
2. Identify EC-OSB hybrid cell secreted factors (EC-OSB factors) that promote PCa progression. EC-OSB
hybrid cell secretome was examined by both iTRAQ (protein) and RNAseq (gene) analyses. Tenascin C was
identified along with CTGF and versican, which together may constitute an “EC-to-OSB signature”. We will
investigate the effects of these EC-OSB factors on PCa cell activity in vitro and in vivo. The “EC-OSB signature”
will also be tested as biomarkers for osteoblastic bone metastasis using clinical samples. Aim 3. Develop
strategies that target EC-OSB hybrid cells to improve therapy outcomes for PCa bone metastasis. The EC-
OSB hybrid cells may contribute to de novo therapy resistance described previously. We will examine whether we
can improve therapy outcomes for PCa bone metastasis by combining cabozantinib or cabazitaxel (targets PCa
tumor) with Rad-223 (targets EC-OSB hybrid cells). Aim 4. Determine whether EC-to-OSB transition occurs
in normal bone and the fraction of EC-OSB hybrid cells in tumor-induced bone. We generated a new Double
Reporter Mice (col11-GFP/Tie2-cre/Rosa-tdTomato), in which EC are RFP+, OSB are GFP+, and EC-OSB are
RFP+/GFP+, to examine whether EC-OSB hybrid cells are involved in normal bone development and their fraction
in tumor-induced bone.

Public health relevance
PROJECT NARRATIVE Prostate cancer is dominated by complications arising from bone metastasis, which often has a lethal outcome. This proposal tests the novel concept that inhibition of endothelial-osteoblast hybrid cells in combination with chemotherapy will decrease prostate tumor growth in bone. The successful outcome of our studies will improve the quality of life and prolong the survival of patients with bone metastasis.